Impact of e-cigarette prevention messages on adolescents

Project Summary/Abstract
While significant progress has been made in reducing cigarette smoking among adolescents, the advent of
electronic cigarettes and vaping devices threatens to undo this progress. While e-cigarettes have potential as
harm reduction tools for adult smokers, they have become the most commonly-used tobacco product among
adolescents. In 2018, the Food and Drug Administration (FDA) declared e-cigarette use among adolescents an
“epidemic” after observing dramatic increases in usage among this population since 2017. Evidence-based
health communication approaches can strengthen young people’s commitment to avoid vaping, and thus
prevent e-cigarette use and nicotine addiction. However, little research exists to provide a basis for effective
communication efforts for e-cigarette prevention. We propose 3 Aims to significantly advance the science of
how to communicate about e-cigarettes in ways that prevent use. For Aim 1, we will identify promising ways to
communicate with adolescents to prevent e-cigarette use. We will achieve this by: 1) identifying promising
prevention message themes (i.e., industry targeting, social norms, addiction) targeted to adolescents (ages 13-
17); 2) vetting these themes with the study team, expert consultants, and a teen advisory panel; and 3)
conducting focus groups to examine adolescents’ responses to the e-cigarette prevention message themes.
For Aim 2, we will develop a set of e-cigarette prevention messages that reduce adolescents’ inclination to try
or use e-cigarettes. We will achieve this by: 1) developing 10 e-cigarette prevention messages based on the
chosen theme(s) from Aim 1 and conducting 30 cognitive interviews to refine the messages; and 2) conducting
a nationally representative study to examine the perceived effectiveness of the e-cigarette prevention
messages in discouraging e-cigarette use. Based on the results, we will select 5 messages to carry forward to
Aim 3’s randomized controlled trial (RCT). For Aim 3, we will evaluate whether evidence-based e-cigarette
prevention messages reduce at-risk adolescents’ willingness to use e-cigarettes (primary outcome) and e-
cigarette use behavior (secondary outcome). We will conduct a 2-arm (intervention, attention control), 3-week
RCT with 506 adolescents, with a 3-month follow up. Study participants will receive daily messages sent to
their mobile phones via text message (i.e., multimedia message service) for 20 days. Other secondary
outcomes are cognitive elaboration, negative affect, e-cigarette beliefs, and social interactions. We will also
examine whether e-cigarette prevention messages have unintended consequences (i.e., increasing willingness
to smoke cigarettes). This research is responsive to funding announcement PAR-18-847, which seeks
population-based, applied prevention research on e-cigarettes among vulnerable populations (e.g., youth). Our
work will address a critical gap in tobacco control research by developing effective communications
that strengthen adolescents’ commitment to avoid e-cigarettes and reduce e-cigarette use, thereby
informing local, state, and national efforts to prevent e-cigarette use and nicotine addiction among adolescents.

Public health relevance
Project Narrative The current epidemic of e-cigarette use among adolescents is of great concern, as e-cigarette use can lead to nicotine addiction and associated negative consequences. The current project will develop and test prevention messages that aim to effectively discourage adolescents from using e-cigarettes. This research will contribute to decreased e-cigarette use and a reduction in associated negative consequences among adolescents.